Wearable alert system for detecting postoperative hypotension

Project Summary
This project aims to develop a low-cost, comfortable, and easy-to-use wearable alert system that
tracks continuous BP non-invasively in patients to notify caregivers of hypotensive events in the
postoperative setting. Postoperative hypotension (POH), when a patient’s mean arterial pressure
(MAP) falls to unsafe levels, commonly <70 mmHg, can occur frequently in the time span between
leaving the operating room and prior to discharge from the hospital. POH is a serious and common
condition that has been shown to be independently associated with poor patient outcomes such
as acute kidney injury, stroke, hospital re-admission, myocardial injury, and death.1–9 During
surgery and recovery in the post anesthesia care unit (PACU) or the intensive care unit (ICU), a
patient’s hemodynamics are closely monitored to support timely interventions and treatment.
However, once the patient is transferred to a lower ward for recovery, patient monitoring is
dramatically reduced. The current method to monitor a patient’s BP in the general ward, which
relies on intermittent spot-checks performed manually every 4-6 hours by the nurse using an
oscillometric BP cuff, is insufficient for detecting POH events. A recent study showed that almost
50% of hypotensive events went undetected by routine vital assessments. There is an unmet
need for a technology that comfortably monitors a patient’s BP in the postoperative setting. Our
core technology is able to non-invasively measure rapid BP changes at any location with a
palpable pulse. The proposed project aims build upon the core technology to create a wearable
alert system that informs caregivers of postoperative hypotensive episodes. To do so, a machine
learning (ML) classifier for detection of hypotensive episodes will be developed through
monitoring in the ICU. This ML classifier will undergo feasibility testing in the PACU and then a
pilot study in the general ward. Successful completion of the proposed aims will result in a proof-
of-concept wearable alert system that continuously monitors BP in the postoperative environment
in a low-profile, wireless, and comfortable manner. Such a technology has huge potential to
change clinical practice through earlier detection of patient deterioration, allowing more timely
intervention and ultimately improved patient outcomes.

Public health relevance
Project Narrative This project seeks to develop a wearable alert system for detecting postoperative hypotensive episodes in patients by directly measuring continuous beat-to-beat blood pressure in a comfortable and unobtrusive manner. It is known that postoperative hypotension is common but can go undetected by current patient monitoring methods, thus resulting in poor patient outcomes. The Vena Vitals wearable alert system will detect when a patient’s mean arterial pressure drops below a defined threshold level and alert caregivers of hypotensive events; such a system has significant potential to improve clinical practice by enabling caregiver intervention, preventing patient deterioration, and improving cost efficiency for the hospital.